High-Dose Medications for Opioid Use Disorder: Effects on Treatment Retention, Drug Use Patterns, and Overdose Risks Amidst the Fentanyl Crisis

PROJECT SUMMARY/ABSTRACT
The ongoing overdose crisis in the US, primarily driven by fentanyl, calls for innovative secondary overdose
prevention strategies to improve engagement with medications for opioid use disorder (MOUD). Research
suggests individuals using fentanyl may require faster or less challenging titration and higher maintenance
doses due to their greater opioid tolerance, which differs from the needs of patients using prescription opioids
or heroin, the populations for whom MOUD was initially developed. However, regulatory and structural
challenges in the US hinder the implementation and rigorous evaluation of such MOUD dosing strategies.
Building on our decade-long track record of collaboration, we propose an international collaborative effort to
evaluate novel MOUD dosing strategies. We will leverage the Vancouver Injection Drug Users Study (VIDUS),
one of the largest and longest-running prospective cohort studies of community-recruited people who use
drugs in the world. The VIDUS well represents sub-sets of MOUD patients who bear a disproportionate burden
of overdose (e.g., those unstably housed). While Canada faces a similar fentanyl-driven overdose crisis, its
more relaxed MOUD regulations have allowed prescribers to implement novel dosing strategies. Further,
VIDUS’ comprehensive dataset integrates rich longitudinal behavioral data (e.g., drug use patterns, nonfatal
overdoses) with urine drug screen results and linked administrative databases (e.g., health insurance records,
pharmacy dispensations, hospital/emergency room admissions, and fatal overdoses), overcoming major
limitations in the US datasets and enabling rigorous evaluation of novel MOUD dosing strategies.
Our proposal falls under Funding option A: Implement and rigorously evaluate strategies, with three specific
aims. Aim 1 is to assess the impact of dosing strategies (i.e., rapid methadone titration, low-dose
buprenorphine induction, and higher maintenance doses) on treatment retention, using marginal structural
models. Aim 2 is to evaluate whether these dosing strategies reduce illicit drug use and the risks of nonfatal
and fatal overdoses, using a comparative interrupted time series design. Aim 3 is to identify barriers and
facilitators to adoption, feasibility, and scalability of the dosing strategies in the US through a targeted literature
review, natural language processing analysis of social media data, and qualitative interviews with MOUD
prescribers. It is designed to ensure that the evidence generated from Canadian settings can effectively inform
the adaptation of dosing strategies into US healthcare systems. This project is timely, as there is growing
recognition in the US that MOUD guidelines may need adaptation to better address challenges posed by the
fentanyl crisis. By addressing challenges with MOUD engagement and overdose prevention, this study aligns
with the CDC’s priority to implement and evaluate innovative secondary prevention strategies for reducing
opioid-related harm. Our interdisciplinary team, including experts in addiction medicine, causal inference, and
data science, is uniquely positioned to contribute insights that will shape future MOUD treatment strategies.

Public health relevance
PROJECT NARRATIVE This project aims to evaluate the implementation of novel dosing strategies for medications for opioid use disorder in the context of the fentanyl crisis. By assessing the impact of rapid methadone titration, low-dose buprenorphine induction, and higher maintenance doses on treatment retention, illicit drug use, and risks of nonfatal and fatal overdose, this research will provide critical evidence to inform and refine clinical guidelines. The findings will also support secondary prevention strategies for reducing opioid-related harms among some sub-groups of patients who bear a disproportionate burden of overdose (e.g., those experiencing unstable housing).